Evaluating hepatitis E virus ribavirin resistance clinical outcomes in the immunosuppressed pig model

RBV Pig Project Summary/Abstract
Hepatitis E virus (HEV) is an emerging zoonotic pathogen endemic in both developing countries and in developed
countries including the United States (U.S.). HEV infects 20 million individuals annually, resulting in 3.3 million
symptomatic cases with 44,000 deaths. In countries like the U.S., HEV prevalence is being recognized as a
danger to immunocompromised individuals where the virus becomes chronic and can result in acute liver failure
among other consequences. Approximately 58-92% of HEV-infected organ transplant recipients developed
chronic HEV infection. Currently the recommended treatment for chronic HEV is ribavirin (RBV). There have
already been clinical cases where RBV has failed to clear HEV infection, resulting in poor patient outcome. RBV
treatment failure has been attributed to single nucleotide variant (SNV) HEV strains that can be circulating as
quasispecies in the host that have shown resistance to RBV and/or enhanced replication. Furthermore, long-
term replication of HEV in the chronically infected host has led to the identification of viral quasispecies that
contained insertions of host ribosomal protein S17 (RPS17) or S19 (RPS19) sequences also leading to
enhanced viral replication and increased host range. How naturally occurring HEV variants with enhanced
replication, such as those harboring RPS17 or single nucleotide variants, contribute to viral pathogenesis is
currently unknown. The immediate goal of this project is to adapt the existing immunosuppressed pig chronic
HEV system to model RBV treatment failure and resulting disease severity due to variant HEV strains. In specific
aim 1, we hypothesize that the immunosuppressed swine model in conjunction with suboptimal RBV treatment
will mimic patient treatment in the clinical setting resulting in novel HEV variants and enhanced disease
pathogenesis. To test this hypothesis, we will experimentally infect immunosuppressed pigs with wild type HEV
or variant HEV, treating some groups with RBV. We can then sequence resulting HEV variants and compare
disease severity between variant and wild type HEV groups. In specific aim 2, we hypothesize that SNV
variants exhibiting enhanced growth potential in vitro will correlate to enhanced disease in vivo in part due to
differential host immune responses. To test this hypothesis, we will characterize the immune response in pigs
infected with wild type HEV, and variant HEV viruses from samples collected during specific aim 1. The long-
term goal of this project is to determine viral and host interactions that dictate the outcome of infection by HEV
and develop strategies and therapeutics that can mitigate poor outcomes. The results from this R21 will be
important for future in-depth mechanistic studies of host factors in HEV infection, especially chronic and cross-
species infection. Our specific aims and long-term objectives align well with NIH mission goals seeking to
enhance health, lengthen life, and reduce illness and disability through understanding viral factors contributing
to liver failure and solid organ transplant rejection.

Public health relevance
Project Narrative Hepatitis E virus is an emerging viral disease that kills over 44,000 people annually worldwide via acute liver failure and other complications. Ribavirin is a drug typically used to treat patients with chronic HEV but variant strains of HEV are already resistant to the drug and appear to enhance disease severity. We are proposing to characterize these variant strains of HEV for the first time, assessing how they damage the host, how the host responds, and identifying potentially new variants utilizing an established porcine animal model.